Sex Differences in Methylome Alterations and Mutational Burden in Early Stage Melanoma

PROJECT SUMMARY/ABSTRACT The proposed project aims to address a current gap in our understanding of the role of biological sex in overall survival among melanoma AJCC TNM stages IIA/IIB/IIC/IIIA/IIIB/IIIC/IIID. We will evaluate methylome alterations and mutational burden in the primary tumors of 1000 melanoma patients with the goal of 1) identifying underlying mechanisms for observed disparities in melanoma overall survival between men and women, and 2) identifying subclasses of methylome alterations and mutational signatures associated with sex and survival.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE The proposed project aims to address a current gap in our understanding of the role of biological sex in overall survival among melanoma AJCC TNM stages IIA/IIB/IIC/IIIA/IIIB/IIIC/IIID. Data from the proposed project will provide insight into the link between sex, epigenetics and genetic mutational load, and melanoma survival, and will provide insight into important biomarkers for melanoma progression, and inform clinical decisions about the use of adjuvant immunotherapy. This important step towards increasing our understanding of the relationship between biological sex, methylation alterations, and tumor mutational burden, will be used to develop additional studies, setting the stage for additional breakthroughs in factors important for melanoma survival.